PCT-KUH: Pittsburgh center for training in kidney, urology and hematology

Professional Development Core Abstract
The overall goal of the Pittsburgh Center for Training in Kidney, Urology and Hematology (PCT-KUH)
Professional Development Core is to develop and support curriculum, activities opportunities and resources
designed to equip trainees with career development skills that will be sustained well past the training period.
Our primary directive is to provide trainees with the information and resources they need to identify, pursue,
and be impactful in a broad range of career paths that will benefit from their scientific training. At the same
time, this core will provide professional development resources for faculty mentors to enhance their mentoring
skills in order to have highly effective mentor-mentee relationships. We have assembled an experienced and
diverse leadership and facilitator structure, a well-rounded curriculum and a supporting learning environment
that leverages the rich resources at the University of Pittsburgh, Carnegie Mellon University and Allegheny
Health Network for professional growth and career exploration. Our specific objectives are: Objective 1:
Impart transformational knowledge, investigative and grant writing Skills. Build trainees' opportunities to
acquire new investigative skills and ability to frame testable hypotheses, and prepare trainees to plan, secure
funding for, conduct, analyze, publish, and promote implementation of significant, rigorous high-quality,
reproducible research. Objective 2: Facilitate career development, exploration and planning. Strategically
position trainees to meet evolving challenges and provide opportunities for career exploration and adaptability.
Objective 3: Build skills for forging productive partnerships, networking and communication. Train
students to generate and refine ideas in partnership with stakeholders, work effectively in teams, communicate
to and learn from diverse audiences, and convey the joy of discovery. Objective 4: Build skills for trainee
resilience and promote wellness Empower trainees to develop intellectual and emotional resiliency to adapt
to new scientific and professional environments. Objective 5: Enhance mentor training. to ensure highly
productive and effective mentee/mentor relationships. We have designed a program that will support trainee's
and mentors' leadership, team building and career development. Most importantly, our trainees, faculty, career
coaches, and their peers and near-peers will foster lifelong strategies and habits that promote career
satisfaction, professional growth, team science, leadership, inclusivity, resilience and plasticity.

Public health relevance
The overall goal of the Pittsburgh Center for Training in Kidney, Urology and Hematology (PCT-KUH) Professional Development Core is to develop and support curriculum, activities, opportunities and resources designed to equip trainees with career development skills that they need to identify, pursue, and be impactful in a broad range of career paths. At the same time, this core will provide professional development resources for faculty mentors to enhance their mentoring skills.